Planning the VICTORY (VIsual ComplicaTions Of PrematuRitY) Study

PROJECT SUMMARY
Retinopathy of prematurity (ROP) is a neurovascular disorder that occurs mainly among extremely preterm
infants. The National Eye Institute (NEI) estimates that every year between 400 and 600 children become legally
blind due to ROP. The goal of this project is to plan a large, multicenter cohort study designed to gather
comprehensive social, clinical, and biomarker data needed to further elucidate the etiology and pathogenesis of
ROP and adverse visual outcomes (AVO) in extremely low gestational age newborns (ELGANs, <28weeks
gestation). The aims of the project are (1) to finalize the consortium and create expert working groups (WGs)
that will tackle the planning tasks in their area of expertise, (2) to develop the study protocol and Manual of
Procedures (MOP), and (3) to outline and perform preliminary and feasibility studies. The planned study will have
multiple innovative elements, the most important being (a) first multicenter observational study with a focus on
ROP/AVO, (b) retina imaging at multiple timepoints after birth, (c) artificial intelligence/machine learning
approaches, (d) social determinants of health, (e) pre- and postnatal biomarker measurements, and (f) visual
and neurodevelopmental outcome assessment.

Public health relevance
PROJECT NARRATIVE Children born several months before term are at increased risk of developing a devastating disease of the retina (retinopathy of prematurity, ROP) and of longterm adverse visual outcomes (AVO) including blindness. The central goal of our project is to design and plan for a large multi-center cohort study in which the relationship between sociodemographic, biological, and clinical risk factors, and ROP/AVO can be elucidated in detail. The specific aims of the project are (1) to finalize the member list for the study consortium, (2) to develop the study protocol and Manual of Procedures, and (3) to outline and perform preliminary and feasibility studies.